CARE4Kids: Administrative Core

PROJECT SUMMARY/ABSTRACT - Administrative Core
Concussion is a form of traumatic brain injury that affects millions annually, particularly adolescents. While
many recover, a large number of injured youth go on to develop persistent post-concussive symptoms (PPCS),
and experience ongoing pain, dysfunction and disability. Due to the variability of concussion and the subjective
nature of post-concussive symptoms, our ability to predict and classify those who develop PPCS is currently
very limited. Research suggests that specific patterns of PPCS may be linked to different underlying
pathophysiology. The primary goal of the CARE4Kids Center Without Walls (CWOW) is to identify measurable
biological markers (blood tests, brain scans, electrical activity, etc.) that will help objectively predict and define
different categories of PPCS. The primary goal of the CARE4Kids CWOW Administrative Core is to
provide the necessary leadership, organization, training and infrastructure to permit efficient
coordination of 6 clinical data collection sites with designated centers able to provide quality control
and maintain and store data. The Administrative Core will provide training and oversight for all data collection
of clinical and biological measures. Biological measures may include cognitive tests, brain electrical activity,
scans of brain structure, molecules in blood or saliva, cardiovascular testing and stress responses. The
Administrative Core also will establish guidelines for the CARE4Kids CWOW to monitor funding, scientific
inquiry, data curation and sharing, and dissemination of results. Other important roles include standardizing
definitions, developing consistent methods and coordinating an annual meeting to ensure the consortium has
an open forum to meet, share information and troubleshoot unanticipated challenges. The results of this work
will lead to improved, but objective, medical tests that help predict which patients with concussions are at
greatest risk for PPCS. By defining objective categories of those at risk for PPCS, it will be possible to better
provide medical care, and will also lead to future trials for new treatments.